Air Pollution Effects on Child Irritability and Brain Connectivity

Project Summary/Abstract
Irritability is common in early childhood and declines as children approach middle childhood. Irritability that
persists into middle childhood affects up to 20 percent of youth and is a marker of risk for psychiatric problems.
To date, the study of irritability has focused on personal (e.g., parenting style) and genetic risk factors for
irritability with little attention focused on the contribution of exogenous, environmental factors, such as prenatal
exposures to neurotoxicants. This K23 application presents a research and training plan that will support the
applicant, Dr. Mariah DeSerisy, on a path towards becoming an independent investigator working at the
intersection of child mental health, environmental epidemiology, and neuroimaging. The activities in this
application build on Dr. DeSerisy’s prior training and are set in a resource-rich environment which will allow her
to further develop her skills in: (1) analyzing effects of polycyclic aromatic hydrocarbons (PAH) using advanced
epidemiologic methods, (2) developmentally sensitive, multi-informant/method assessment tools for early
childhood irritability, (3) longitudinal modeling of high-dimensional data using causal inference approaches, (4)
network-based functional connectivity magnetic resonance imaging (MRI) data analysis, and (5) ethical
conduct of research with vulnerable populations. By combining MRI and environmental epidemiology, the
current research proposal seeks to test the central hypothesis that prenatal PAH exposure is associated
with persistent irritability via effects on functional connectivity between control and reward circuits.
This training and research program will support the candidate in becoming an independent investigator with
expertise in how environmental (social and chemical) risk factors contribute to the manifestation of adolescent
internalizing symptoms and anxiety/depressive disorders.
RELEVANCE: Air pollution is an understudied, modifiable risk factor for an environmentally-associated
phenotype of persistent childhood irritability. In the short term, this career development award will provide Dr.
DeSerisy with critical training that will prepare her to successfully submit an R01 examining the contributions of
prenatal PAH to adolescent anxiety and depression via persistent irritability in this cohort. Long term, results
may inform public policy messaging and contribute to development of novel intervention and prevention tools.

Public health relevance
Project Narrative Persistent irritability in childhood impacts up to 20 percent of youth and is associated with elevated risk for adolescent mental health problems, such as anxiety and depression, as well as significant functional impairment, including school problems, family problems, and problems with peers. By seeking to understand how prenatal exposure to PAH affects children’s irritability and brain function, this project is a first step towards identifying modifiable environmental risk factors and establishing potential etiologic pathways for persistent irritability. Such knowledge may be used in public health interventions to improve the quality of children’s environment and support the development of novel treatment options for children with irritability.